Admin Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Exploratory Vanderbilt Alzheimer’s Disease Research Center (VADRC) Administrative Core is central to
achieving the overall mission of the VADRC and will leverage strong institutional resources to provide excellent
administrative oversight for a scalable infrastructure to position Vanderbilt University Medical Center and
Vanderbilt University for a future successful P30 application. Under the proven leadership of Dr. Angela
Jefferson, supported by Associate Directors, Dr. Consuelo Wilkins and Dr. Charles Sanders, the Administrative
Core is uniquely positioned to achieve this goal. Our interdisciplinary Core leadership will ensure that all
programmatic objectives of the VADRC are accomplished by coordinating and integrating VADRC Cores and
scaling these Center functions into a thriving P30-funded ADRC. Core leadership will drive the Center’s
scientific direction emphasizing non-amyloid pathways of injury, including understanding vascular contributions
to Alzheimer’s disease and related dementias, discovering novel disease pathways using advanced
techniques, and improving pharmacological therapies for Alzheimer’s disease and related dementias. The
Administrative Core will serve as the institutional hub for all local Alzheimer’s disease research activities by
providing strategic planning, scientific direction, campus-wide integration, and essential infrastructure. Core
leadership will identify opportunities for growth while harnessing strengths of existing programs. The
Administrative Core will establish and facilitate administrative structure, Center governance, and oversight for
Center operations. These functions include managing budgetary oversight, ensuring compliance with
regulatory requirements, facilitating ongoing internal and external review and evaluation of VADRC activities,
and coordinating fiscal, operational, and regulatory functions to ensure effective utilization of Center resources.
The Administrative Core will actively support local research activities and contribute to collaborative national
research initiatives and resource sharing to advance the goals of the National Alzheimer’s Project Act.
Leadership will establish a scalable data sharing platform to support a future P30 Data Management and
Statistical Core. Such infrastructure will promote coordinating and integrating VADRC activities for data
transfer that serve local investigator needs and support national research efforts (e.g., National Alzheimer’s
Coordinating Center, National Centralized Repository for Alzheimer’s Disease and Related Dementias).
Additionally, the Administrative Core will support VADRC participation in multi-site clinical trials. Finally, the
Core will be integral in fostering professional development of the next generation of clinicians and scientists in
Alzheimer’s disease. Collectively, the VADRC Administrative Core will be instrumental in establishing and
facilitating harmonized integration between all Center investigators, collaborators, Core functions, institutional
resources, and national partners, which will facilitate a smooth transition to a future P30-funded VADRC.